Translating Intestinal Radioprotection by EGLN Inhibition to Improve Clinical Outcomes in Unresectable Pancreatic Cancer

PROJECT SUMMARY/ABSTRACT
Pancreatic cancer is almost always fatal and new approaches are needed to improve the prognosis for
a disease that is now the third leading cause of cancer-related death. Pancreatic cancer cannot be cured
without surgery, and unfortunately, nearly 90% of patients present with unresectable disease (locally advanced
+ metastatic), leaving patients and clinicians with very few treatment options once chemotherapy is completed.
Radiation therapy cannot substitute for surgery because of morbid radiotoxicity to the nearby stomach and
intestines that occurs before the tumor is controlled. Thus, treatment-related gastrointestinal (GI) radiation
toxicity may be the single greatest barrier to improving treatment responses for unresectable pancreatic
cancer. There are no known medications that can selectively protect the stomach and intestines from these
side effects, but we previously published that the inhibiting signaling through EGLN proteins reduces radiation
damage in a model of catastrophic radiation injury and now we propose to understand these effects in a
clinically relevant system. Our laboratory's long-term goal is to develop therapies that reduce sequelae from
radiation injury during clinically relevant and potentially curative cancer treatments. The central hypothesis is
that inhibition of the EGLN enzymes, achieved through the use of the oral EGLN inhibitor FG-4592, will
selectively protect the intestinal tract from radiation toxicity without protecting tumors. The objective of this
grant is to uncover a deeper understanding of how the EGLN signaling axis modulates the radiation esponse in
the intestinal stem cell niche and in pancreatic tumors in order to safely translate this technology to patients.
The specific aims will test the following hypotheses: (Aim 1) EGLN inhibition reduces radiation toxicity to
enable ablative stereotactic radiation for pancreatic cancer, which will improve survival; (Aim 2) EGLN
inhibition works chiefly by stimulating the +4 intestinal stem cells, which will be tested with a lineage tracing
experiment in reporter mice; (Aim 3) FG-4592 will selectively protect human intestinal tissue from radiation
damage but not human pancreatic cancer. The proposed research is significant because FG-4592 has
completed Phase III clinical trials for a non-oncologic indication and could thus be rapidly implemented as a
radioprotector. This approach could be used potentially replace surgery with radiation for patients with
unresectable pancreatic cancer and serve as the basis for a clinical trial in the next 5 years. This research is
innovative because it takes a multidisciplinary approach to solving a complex clinical problem in an area with a
significant unmet need. We use patient derived tumor organoids and intestinal “mini-gut” cultures that have
been generated at our institution to model this complex biology before a clinical trial with patients and
moreover use cutting-edge techniques like single cell RNA seq to interrogate stem cell dynamics of the
intestine in response to radiation injury and EGLN inhibition.

Public health relevance
Project Narrative/Public Health Relevance Pancreatic cancer is a deadly disease where a cure can only be achieved through surgery, but only a small number of patients can get an operation. High-dose radiation therapy could replace surgery and improve outcomes in unresectable pancreatic cancer, but only if the side effects of radiation are reduced with a radioprotective class of drugs called EGLN inhibitors. This proposal will study the cellular and molecular mechanisms of EGLN inhibitors in both normal tissues and tumors to help quickly bring these drugs to clinical trials for the nearly 45,000 patients a year who are diagnosed with unresectable pancreatic cancer.